From Court to the Community: Improving Access to Evidence-Based Treatment for Justice-Involved Youth At-Risk for Suicide

PROJECT SUMMARY
Justice-involved youth (JIY) living in the community experience disproportionately high rates of suicidal thoughts
and behavior (STB) and non-suicidal self-injury (NSSI) compared to adolescents in the general population. Many
JIY lack access to evidence-based treatment specifically designed to treat NNSI and STB, thereby increasing
the overall risk of suicide in this population. Further, even when JIY do have access to evidence-based treatment,
treatment initiation in this population is low. The current proposal aims to reduce STB and NSSI among JIY, and
thus reduce mental health differences in this vulnerable youth population in need of services. Our primary aim is
to implement a systems-level training program, used by the investigators on psychiatric inpatient and emergency
services, designed to increase access to evidence-based treatment strategies specifically designed to treat STB
and NSSI behaviors for JIY referred to outpatient care by the Rhode Island Family Court, approximately 1,125
over a 5-year period. We will conduct a cluster randomized stepped wedge trial in which 9 distinct community
mental health agencies (CMHA) who serve JIY in the state of Rhode Island will be randomized to receive a
standardized training program. CHMA administrators and providers will complete semi-structured qualitative
interviews and self-report measures pre-implementation. The self-report measures will be repeated postimplementation,
and sustainment. Guided by the RE-AIM framework, we will identify agency/system-level and
provider-level factors that may promote or hinder the uptake, implementation, and maintenance of the evidencedbased
treatment strategies for STB and NSSI in CMHAs serving JIY living in the community. It is hypothesized
that at the systems level, the training program will be sustained for at least one year, and up to 3 years in some
cases, by CMHA administrators. At the provider level, it is hypothesized that training in the use of evidencebased
treatment strategies for STB and NSSI will significantly increase both the use of these strategies and the
quality of their delivery post-implementation. At the patient level, we hypothesize that the training program will
improve adherence to outpatient treatment, increase receipt of evidence-based treatment strategies, and reduce
rates of adolescent STB and NSSI that require emergency medical/psychiatric care. This application has strongly
aligns with the goals of RFA-MH-21-187, to test effective “systems-level strategies for the detection and
prevention of SIB and/or NSSI specifically among underserved children and adolescents.”

Public health relevance
PROJECT NARRATIVE Suicidal thoughts and behaviors and non-suicidal self-injury are disproportionally high among justice involved youth (JIY). This study aims to collaborate with community mental health agencies who serve JIY to enhance the implementation of effective system-level interventions for detecting and treating non-suicidal self-injury and suicidal thoughts and behavior in justice-involved adolescents. This work has the potential to better understand what agency-specific factors facilitate the successful implementation of evidence-based assessment and treatment for suicidal JIY living in the community and will yield practice-relevant information regarding scalability, implementation, and dissemination of treatment in the community.